Imaging post-traumatic osteoarthritis 10-years after ACL reconstruction: a multicenter cohort study with quantitative MRI

PROJECT SUMMARY/ABSTRACT
Anterior Cruciate Ligament (ACL) injury is a proven high-risk factor for post-traumatic osteoarthritis
(PTOA) development despite ACL reconstruction (ACLR). However, our understanding of PTOA development
after ACLR is limited, and reliable “markers” (risk factors) that provide early diagnosis and prognosis are still
lacking. Long-term studies of PTOA after ACLR primarily used radiographs for evaluating structural damage,
which only provided information limited to bone changes that occur at late stages of the disease. Previous MRI
studies after ACLR are primarily limited to short/mid-term follow up. The long-term degeneration of soft tissue,
their relationship to each other, and to patient symptoms and outcomes after ACLR are largely unknown.
In this study, we aim to fill this gap and propose to add morphologic and quantitative MRI (qMRI) to the novel
nested cohort from the Multicenter Orthopaedic Outcomes Network (MOON) at 10 years after ACLR. The NIH
funded MOON study was designed to follow ACLR patients after surgery to determine their clinical outcomes
including risk factors for the initiation and progression of PTOA. The MOON cohort is unique in the world with
>3500 participants and greater than 80% follow-up at 2, 6, and 10 years. The MOON group has published
extensively on multivariable modeling on risk factors for patient reported outcomes measures (PROMs), and
infrequent outcomes (graft failure, infection, total knee arthroplasty). Further, a novel nested cohort (n=425) was
initiated within the MOON cohort which consists of young active patients with a comprehensive research
evaluation including radiographs, physical and instrumented laxity examination, and functional testing. In this
study, we will add state-of-the-art qMRI to this nested cohort to evaluate cartilage (thickness and matrix
composition T1r and T2), bone (3D shape modeling), muscle (volume and fatty infiltration), and other OA-related
lesions. The overarching goal of the study is to characterize long-term structural damage and articular cartilage
degeneration after ACLR, understand their patterns and relationship to patient outcomes, and identify modifiable
predictors for PTOA at 10 years after ACLR from pre-operative and early postoperative time points. Furthermore,
the MRI measures, such as cartilage T1r and T2, at 10 years will also serve as potential predictors for future
PTOA development (for those who do not develop PTOA at 10 years), failure of the ACLR graft or contralateral
ACL, and additional arthroscopic surgery at the 20 years post-ACLR MOON time point.
The proposed study will leverage resources from the NIH funded MOON grant, and this is a unique, first
ever, opportunity to comprehensively evaluate the knee structural damage and their interrelationship with patient
outcomes at 10 years after ACLR in a prospective, well characterized and closely monitored cohort. By identifying
modifiable predictors of structural damage at 10 years after ACLR from baseline and early postoperative time
points, this study can have immediate impact on improving patient management and treatment, as well as lead
to further RCT on identified modifiable risk factors to reduce and prevent PTOA following ACLR.

Public health relevance
NARRATIVE/RELEVANCE Patients with anterior cruciate ligament (ACL) ruptures tend to develop post-traumatic osteoarthritis (PTOA) despite ACL reconstruction (ACLR). This proposed study will add state-of-the-art MRI to the NIH funded Multicenter Orthopaedic Outcomes Network (MOON) nested cohort patients at 10-years after ACL reconstruction. The study has the potential to identify risk factors for PTOA development after ACLR, and improve management to patients with ACL injury and reconstruction.